Cultivating Regular Physical Activity: Associations among Purpose in Life, Physical Activity, and Cognitive Function in Alzheimer's Disease and Related Dementias

Abstract
Physical activity (PA) is a significant area of research in aging, dementia, and cognitive impairment (CI),
but regular PA may be challenging to begin and sustain for older adults with cognitive impairment (OACI). One
way to engage OACI in PA is to set goals to enhance motivation. While this has succeeded in rehabilitative
settings and residential care facilities, there remains a gap in knowledge on PA goalsetting among community-
dwelling OACI to maintain function and independence. A recent area of interest in PA and goalsetting is
purpose in life (PiL), which is defined as the subjective experience of living with meaning and direction. Older
adults with greater PiL tend to be more physically active, likely because they connect their PiL and long-term
goals with the importance of PA. However, utilizing PiL as motivation for regular PA likely requires higher-order
cognitive abilities that older adults with more advanced CI may not have. Furthermore, while the most currently
validated PiL measurement developed by Ryff and colleagues has been successfully administered among
OACI, there is concern that this PiL measurement may not entirely suit the circumstances of OACI. Since
preliminary analyses further found that this measurement did not fit data from the Health and Retirement Study
(HRS) well among OACI, there is a need to refine the measurement of PiL for OACI to ensure applicability.
The goal of this study is to understand who can connect PiL to PA among OACI and how. Aim 1 refines the
measurement of PiL among OACI using the HRS. Items from Ryff's HRS PiL framework will be assessed using
a confirmatory factor analysis (CFA) for applicability to OACI based on current literature, and a modified model
will be proposed using a subset of HRS PiL items. Aim 2 employs the HRS to evaluate the association
between PiL and PA among older adults with varying degrees of CI. This aim is based on the hypothesis that
the degree of CI moderates the association between PiL and PA, such that the association between PiL and PA
is similar and strong among older adults without CI and older adults with mild cognitive impairment (MCI) but
weaker among older adults with dementia. Lastly, Aim 3 qualitatively investigates how older adults with MCI
and mild dementia evaluate PiL and incorporate PiL into PA goalsetting. The authors propose that connecting
one's PiL to one's PA goals leads to enhanced motivation for and engagement in regular PA. This aim uses the
ongoing Promoting In-Home Activities at a Memory & Aging Clinic (P30AG022849-19 sub-fund, PI:
Muramatsu), a PA intervention with PA goalsetting for inactive older adults with MCI or mild dementia. Aim 3
will identify participants' PiL, support the development of personalized and meaningful PA goals, and observe
how participants engage in the PA intervention when involving their PiL. Findings from this study will be
triangulated and used to develop themes for clinical tools to motivate OACI to engage in regular PA.

Public health relevance
Project Narrative Physical activity is a significant area of research to prevent and delay Alzheimer's disease and related dementias (AD/ADRD). However, little is known about how to effectively and meaningfully motivate older adults with cognitive impairment to start and maintain regular physical activity. This proposal will investigate the associations between purpose in life, regular physical activity, and cognitive function among older adults with cognitive impairment to understand better how this population can be meaningfully motivated to be physically active.